QUANTITATIVE IMAGING AND SPECTROSCOPY IN MULTIPLE SCLEROSIS

The study aims to develop new magnetic resonance methods to evaluate MS. The data may provide information useful in sub-catagorizing MR-identified lesions into primarily demyelinating or primarily edematous or gliotic. These lesions will be commpared with the clinical data to understand the relationship between clinical signs and symptoms and the appearance, persistance, or disappearance of MS lesions on MR.